Center for Appalachian Research in Environmental Sciences-Administrative Core

PROJECT SUMMARY – Administrative Core
The University of Kentucky Center for Appalachian Research in Environmental Sciences (UKCARES)
Administrative Core will coordinate, oversee, and evaluate all programmatic and scientific
activities and lead cross-disciplinary career development initiatives, while providing and receiving
support from the Translational Research Support Core, the Analytical Chemistry Core for
Environmental Sciences, the Community Engagement Core, the Pilot Project Program, and our
community partners. The Administrative Core leadership is comprised of highly regarded senior
scientists and research mentors who are well qualified to operate an Environmental Health
Sciences Core Center (EHS CC) that is responsive to the concerns of people in rural Appalachia
and to advance EHS across the translational spectrum. The Administrative Core will actively
collaborate with all Center members, community and academic, promoting their research and
involving them in Center decision-making and strategic programmatic activities, as well as
engaging with other UK Centers and EHS CCs. The organizational structure of UK-CARES will allow
for optimal multidirectional Center-Community-University communications and institutional
support. Three Advisory Boards will inform our research, provide advice and support, help us form
and maintain robust community-academic partnerships, and evaluate program progress: 1) a 12-
member Stakeholder Advisory Board representing higher education, environmental organizations,
healthcare, and public health in rural Appalachia; 2) an Internal Advisory Board comprised of 10
high-level campus and community decision makers; and 3) a 4-member External Advisory Board of
prominent national leaders in EHS. The Administrative Core has four Aims to: 1) coordinate,
monitor, and evaluate the Center’s scientific and programmatic activities; financial oversight and
regulatory compliance; productivity; and effectiveness as intellectual needs change; 2) facilitate
internal multidirectional communication and responsible conduct of research; 3) facilitate external
multidirectional communication; and 4) cultivate careers in EHS. The Core will ensure effective
internal and external communications by directing monthly Executive Committee meetings;
coordinating an Annual Scientific Retreat, monthly scientific work groups with Center members,
and a seminar series; and partnering with key
community and state partners via social media, our website, and other scientific and professional
venues. The Core’s Career Development Program will recruit and support early-stage investigators
(ESIs) to become independent EHS researchers and facilitate established investigators to
transition to an EHS research focus through maximizing the use of Center services, crossdisciplinary
activities, and mentorship. Career Development Program funding will support
independent investigators newly recruited to UK, from outside UK- CARES, or Center member ESIs
with partial salary support. In the first cycle, the Administrative Core has grown the Center as a
recognizable entity in EHS and public health in rural Appalachia.